Center for Youth Equity (CYE) at Tulane University: A Community-Centered Approach to Youth Violence Prevention

CYE PROJECT SUMMARY: This proposal responds to RFA-CE-21-005 and establishes the first CDC-
funded Prevention Research Center in the Gulf South explicitly focused on youth violence prevention. The
scientific premise of the proposed Center for Youth Equity (CYE) is that the complex nature of youth violence is
embedded in historical and current structural racism and its impact. The root causes and disproportionate rates
of youth violence in African American (AA) communities are shaped by the need for community-centered,
strengths-based approaches that address critical barriers to prevention, including: (1) the interconnectedness
of youth violence and systemic racism, and lack of cohesive strategies that capitalize on the inherent energy
and insights of youth, (2) the lack of strong community-centered approaches in which youth and community
organizations with deep knowledge and understanding of systemic racism and violence participate in the
creation of solutions, and (3) the paucity of comprehensive harm reduction approaches to reduce gun violence
amongst youth. The objective of the CYE is to address these barriers through a long-term, transdisciplinary
effort that centers equity and supporting infrastructure, including Administrative, Research, Outreach &
Translation, and Education & Training Cores. Our overall aims are: (1) to establish a culturally responsive
youth violence prevention research center embedded within the ongoing community partnerships and existing
infrastructure of the Tulane University Violence Prevention Institute (VPI) to build and strengthen the network
for youth violence prevention in the Gulf South; (2) to adapt, implement, and evaluate a multicomponent
sociopolitical development enrichment and empowerment program to prevent and reduce exposure to police
violence among younger AA youth (10-17 years) through youth-led grassroots organizing and activism for
social and structural change; (3) to evaluate the effects of a hospital-initiated, community-integrated practice-
based approach in reducing gun violence among older youth (18-24 years); (4) to translate the evidence base
for community youth violence prevention strategies into widespread outreach and dissemination efforts; and (5)
to develop innovative and transdisciplinary educational and training opportunities for early career and junior
scholars and professionals aimed at developing and sustaining a workforce well-positioned to impact youth
violence prevention efforts locally, regionally, and nationally. The mission of the CYE is to serve as a hub for
innovative research, community-engaged outreach and translation, and cutting-edge training and education in
youth violence and injury prevention nationally, locally, and throughout the Gulf South region.

Public health relevance
CYE PROJECT NARRATIVE: The proposed Center for Youth Equity (CYE) at Tulane University would be the first CDC-funded Prevention Research Center in the Gulf South explicitly focused on youth violence prevention, despite a significant need for such a resource—especially in states like Louisiana, Mississippi, and Alabama with the top homicide rates in the country. The CYE is relevant to public health because it will integrate, build upon, and transform interdisciplinary research, outreach, and training programs to create a synergistic hub and resource for youth violence and injury prevention in the Gulf South region. The proposed center is relevant to the mission of the CDC's National Center for Injury Prevention and Control because it aims to prevent and reduce violence, injury, and their resulting consequences and health disparities, particularly in a hard-hit city like New Orleans, Louisiana and the Gulf South region.